Defining the role of extracellular matrix mechanics in vascular Ehlers-Danlos syndrome

PROJECT SUMMARY
Vascular Ehlers-Danlos syndrome (EDS Type IV, vEDS) is a variant of Ehlers-Danlos syndrome (EDS)—a family
of connective tissue disorders with 13 defined subtypes—that is caused by mutations in the COL3A1 gene.
These mutations result in reduced collagen III in the vascular ECM and typically leads to aortic dissection and
aneurysm, resulting in vessel rupture. In vEDS and other EDS variants there is evidence that ECM content,
protein structure, and mechanical properties are altered. Vascular endothelial cells (ECs) sense and respond to
ECM composition and mechanical properties, and pathologic changes to ECM, including increased stiffness,
can induce effector signaling that results in increased vascular permeability and secretion of factors such as
vascular endothelial growth factor and nitric oxide. Such changes in EC phenotype and function, broadly referred
to as endothelial dysfunction and can contribute to vascular diseases, such as in aneurysm formation. I
hypothesize that mutations in the COL3A1 gene alter ECM mechanical properties, as a result of protein content
and structural changes in the ECM, which leads to EC dysfunction and results in weakened vasculature. I will
address this hypothesis with three aims using a combination of in vitro and in vivo methods. In Aim 1, I will
address the impact of COL3A1 mutations on ECM composition and mechanical properties using cell-derived
matrix (CDM) from vEDS patient-derived cells in vitro to determine how mutations in COL3A1 alter elastic and
viscoelastic properties of ECM. In Aim 2, I will address how changes in mechanical properties of vEDS CDM
relates to vascular EC phenotype and function. I will analyze endothelial cell response to vEDS CDM with varying
stiffness to decouple ECM protein content and mechanics to define specific mechanisms by which pathologic
CDM influences endothelial cell phenotype and vascular barrier function. In Aim 3, I will address the impact of
both endothelial dysfunction and changes in ECM mechanical properties on disease progression in vivo. I will
use an established mouse model of vEDS to investigate both endothelial cell phenotype and ECM mechanics in
addition to vascular rupture events and overall tissue fragility to probe the link between changes in EC phenotype
and aortic mechanical failure. This proposed work will identify how compromised ECM mechanical properties
impact vEDS disease manifestation through the probing of endothelial cell signaling pathways related to vascular
function, inflammation, and mechanotransduction. A better understanding of these pathways will lead to new
routes of treatment for vEDS patients – of which there are none currently approved by the FDA. Further, these
mechanisms of failure are likely more broadly relevant for aneurysm formation and progression in general (not
just in vEDS patients) and may be of help for furthering research of identifying, treating, and preventing
aneurysms.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Vascular Ehlers-Danlos Syndrome is a rare disorder that results in patient mortality due to aortic dissection and vascular rupture of aneurysms that has no FDA approved treatments. The proposed work aims to investigate the role that the mechanical properties of the extracellular matrix play in promoting endothelial dysfunction and exacerbating the formation and rupture of vascular injuries. The results of these studies will elucidate new pathways governing the formation of aneurysm, thus paving the way for the development of new therapeutics for aneurysm treatment and prevention.